Development of Anti-ceramide scFv as Mitigator of the Radiation GI Syndrome

Project Summary/Abstract Inhibition of ceramide protects mice from death from the Radiation GI Syndrome (RGS). Administration of anti- ceramide single-chain Fv (scFv) 24 h post radiation exposure increases survival in intestinal stem cells and dramatically improves overall survival in mice. These data indicate that anti-ceramide scFv represents the first effective mitigator of lethal RGS. To advance the development of anti-ceramide scFv towards an Investigational New Drug application filing, we propose to 1) characterize the PK/PD relation with efficacy in mice; and 2) utilize PK/PD to select doses of anti-ceramide scFv to evaluate in a pilot efficacy study in a non- human primate (NHP) model of the RGS. Successful completion of the proposed aims will provide rationale for evaluation of anti-ceramide scFv safety in humans and full evaluation of efficacy in a larger powered NHP trial. Single-chain antibody fusion proteins are smaller derivatives of full length antibodies, and thus offer the advantage of rapid entering into the bloodstream efficacy and increased penetration into tissue compared to full-length antibodies, and from a product development standpoint these fusion proteins can be produced easily and at minimal cost. As such, a neutralizing anti-ceramide single-chain antibody fusion protein represents a promising candidate to fulfill the Project BioShield mandate for development of countermeasures to mitigate acute radiation syndromes within the first 24 h after a nuclear disaster.

Public health relevance
Narrative: The acute Radiation GI Syndrome (RGS) is a potentially-lethal radiotoxicity for which currently there are no effective medical countermeasures. Preclinical data demonstrate that an anti-ceramide single-chain variable fragment (scFv) mitigates RGS denudation of small intestinal mucosa and death of mice when administered at 24 hours after exposure to a high dose of ionizing radiation. Studies proposed here will detail Ceramedix LLC's development plan for anti-ceramide scFv as a mechanism-based approach to mitigate RGS lethality.